Implementation of an impact assessment tool to optimize responsible stewardship of genomic data in the cloud

PROJECT SUMMARY/ABSTRACT
The goals of the proposed research address the NHGRI strategic vision of improving how publicly funded
genomic repositories measure and report the impacts of their stewardship in novel computing environments.
More genomic and related health data are generated than can be securely accessed and shared, preventing
scientists’ ability to drive innovations that improve human health. New platforms powered by cloud technologies
are transforming how repositories FAIRify data at scale, making data more findable, accessible, interoperable
and reusable for otherwise compliant biomedical research. Moving repositories beyond regulatory compliance
to responsible stewardship of public data resources means aligning institutional practices for data release with
the values and interests of diverse stakeholders (e.g. data producers, users and contributors). The impacts of
genomic data stewardship have been challenging to capture in the cloud so far because we lack understanding
of what stewardship outcomes matter most to key stakeholders and how to measure these outcomes over time.
It is expected that most largescale genomic data collections will soon migrate to the cloud. The time is now for
developing a reliable tool that can track progress on genomic data stewardship ahead of these major
infrastructural upgrades. The proposed K01 Mentored Research Scientist Development Award is designed to
build Dr. Rahimzadeh’s foundational knowledge in privacy engineering and law, and to develop core
competencies in impact assessment necessary to launch an independent research career at the nexus of
genomics, bioethics and data science. Dr. Rahimzadeh is an applied bioethicist with scientific training in
genomics. Her long-term career goal is to inform governance decisions which sustain public trust in and
maximize the scientific value of genomic data resources across the research lifecycle. The integrated training
and career development plan will be coordinated at the Center for Medical Ethics and Health Policy and
leverages the expertise of an interdisciplinary team of bioethicists, genomic researchers, privacy engineers and
data scientists. Dr. Rahimzadeh will partner with international data stewards responsible for managing
genetically diverse data collections across repositories represented in the Global Alliance for Genomics and
Health, H3Africa and the Native BioData Consortium to achieve the following specific aims: (AIM 1) Characterize
essential outcomes and develop assessment criteria for genomic data stewardship in the cloud using a modified
Delphi study design; Validate a stewardship impact assessment tool with experts in cloud infrastructure design
(AIM2A) and pilot test the tool’s implementation with managers across cloud-native repositories (AIM2B).

Public health relevance
PROJECT NARRATIVE Cloud computing promises to scale up storage, analysis and sharing of health data needed to accelerate research in genomics and precision medicine but methods for evaluating how responsible access to and sharing of genomic data is governed in the cloud remain severely underdeveloped. The proposed K01 aims to develop, validate, and implement a reliable tool in partnership with global stakeholders to assess genomic data stewardship across publicly funded repositories worldwide. Findings from this project will expand current strategies for ensuring stewardship systems reinforce community values and proposes a transparent model for reporting stewardship impact among cloud-native repositories going forward.